Use of microfluidic tumor cultures to enable clinical trials of therapies for ovarian cancer

ABSTRACT
With an estimated 20,000 new cases and 13,000 deaths in 2024, ovarian cancers (OCs) remain the deadliest
gynecological malignancy. Despite the heterogeneity of this group of cancers in terms of histology, possible cell
of origin, and genomic alterations, OCs are almost universally treated with surgery and adjuvant or neoadjuvant
chemotherapy that includes the platinum coordination compounds carboplatin or cisplatin. The vast majority of
OCs relapse after this treatment and, whether treated with further platinum agents or other therapies, become
more resistant with each subsequent therapy. Platinum-resistant ovarian cancer, i.e., ovarian cancer that recurs
within 6 months of the most recent platinum-containing therapy, has a median survival of 6-20 months despite
the development of newer targeted agents, highlighting the need for improved therapies. In this context, two
projects of the Mayo Clinic Ovarian Cancer SPORE (P50 CA136393) are developing and testing two new
therapies for platinum-resistant ovarian cancer. Project 2 involves preclinical studies and a phase II clinical trial
PLX038, a sustained release formulation of the active TOP1 inhibitor (TOP1i) SN-38. Project 4 involves the
development and subsequent phase I clinical testing of natural killer (NK) cells that have been transduced with
a chimeric antigen receptor (CAR) targeting mesothelin and modified to sustain their survival and function in
vivo. A goal in both projects is identification of OC patients most likely to benefit from these treatments.
With previous funding from the NCI Innovative Molecular Analysis Technologies (IMAT) Program, the PIs of this
revision project have developed microfluidic devices that permit prolonged survival and proliferation of patient-
derived organoids (PDOs) and tumor explants in 3-dimensional culture. A major advantage of these devices is
the ability to assess the impact of various treatments, including small molecules and cellular therapies, on both
tumor cells and cells in the tumor microenvironment. The revision project will test the hypothesis that responses
to therapy in these microfluidic devices correspond to responses of patients treated with the same therapies on
the two SPORE-associated clinical trials. In particular, the proposed project will i) compare the TOP1i response
of OC patient-derived xenografts (PDXs) treated with PLX038 in vivo with their response, including stabilization
of TOP1-DNA covalent complexes and shrinkage, when treated with TOP1i in the microfluidic devices ex vivo
(Aim 1); ii) assess the survival, functionality (as measured by cytokine secretion) and killing potency of NK cells
expressing CISH miRNA and a MSLN CAR when added to fresh OC explants in the microfluidic devices (Aim 2);
and compare the responses of tumor explants cultured with TOP1i or modified MSLN CAR NK cells in microfluidic
devices ex vivo with the responses of the source patients to the same treatments in vivo in the course of two
SPORE-associated clinical trials (Aim 3). These proposed studies will simultaneously identify whether these
devices are able to predict responses to two different types of OC therapy and position the devices as potential
companion diagnostics for further development.

Public health relevance
NARRATIVE With previous funding from the NCI Innovative Molecular Analysis Technologies (IMAT) Program, the PIs of the proposed revision project have developed microfluidic devices that permit the culture of small tumor samples (patient-derived organoids and fresh explants) under a variety of conditions, including in the absence and presence of therapeutic agents. Advantages of this technology include i) the presence of a host immune system and tumor microenvironment, ii) the ability to analyze cytokines and other molecules secreted into the tumor microenvironment, and iii) the facile harvesting of cells for single-cell RNA sequencing and other ‘omic analyses. The present application proposes the incorporation of this new technology into two existing projects in the Mayo Clinic Ovarian Cancer SPORE. In both projects, the responses of ovarian cancers to treatments in the microfluidic devices ex vivo will be compared to the responses of the same tumors in patients treated with the same therapies in vivo. If a correlation between ex vivo and in vivo responses is observed, this will provide a novel means of identifying patients likely to respond to the tested therapies and also advance development of the microfluidic devices as potential companion diagnostics in other settings.